SERCEB Development Project Program

The SERCEB Developmental Projects Program aims to stimulate and support new and innovative investigator-initiated breakthroughs in biodefense and emerging infectious disease (BD/EID) research. The general goal is to enhance discovery and early phase development of new vaccines, therapeutics, diagnostics and platform technologies for BD/EID, and to help bring new investigators into the field. The SERCEB Developmental Projects Program will enhance our research programs in host-pathogen interactions and interventions.

Public health relevance
Through the ability of SERCEB to seek out and award funds to investigators with new and inovative ideas in biodefense, breakthoughs in the field can be faciliated more easily than through traditional funding methods.